Research Experience and Training Coordination Core

PROJECT SUMMARY
The University of Kentucky Superfund Research Center (UK-SRC) e addresses a major environmental issue,
focusing on halogenated organics occurring at Superfund sites and that persist in the ground and water
sources in many other locations nationwide. The Research Experience and Training Coordination Core
(RETCC) aims to train students to investigate these issues via exposing trainees to interdisciplinary
approaches to training, providing opportunities to enhance their professional career development, and through
extensive outside laboratory experiences program that coordinates opportunities for participation in the
Community Engagement Core and the Administrative Core’s research translational function, and engaging
them with the Data Management and Analysis Core (DMAC). These diverse activities will give the trainees
broad exposure to environmental issues that affect their surroundings and equip them with a unique toolset to
make disruptive impacts to the field. Addressing environmental challenges requires an integrative approach
that leverages knowledge from disparate disciplines and perspectives. A combination of knowledge and
scientific methods from biomedical and environmental science and engineering-based disciplines are required,
while also considering the social impact of these issues on the surrounding communities. While the RETCC
promotes strong cross-disciplinary training, it also encourages the interdisciplinary thinking needed to develop
problem-solving skills and to become effective environmental communicators. The specific aims are: 1) to
introduce innovative training components designed to spur disruptive impacts and spark creative solutions to
complex environmental problems. The RETCC will fund trainee-developed pilot grants that necessitate cross-
disciplinary collaborations (e.g., data science/bioinformatics) among the projects and cores; 2) to integrate
career development training activities critical for academic and nonacademic interests developed through
interactions with the Kentucky Center for Clinical and Translational Science and newly developed DMAC and
offer specific skills training (responsible conduct of research and grantsmanship) that prepare students for
success in academic, governmental and industrial research careers; and 3) to increase integration of the
trainees throughout all aspects of the Center to enhance overall productivity and to expand training
opportunities, from recruitment of the next generation of trainees to reporting the Center’s activities and trainee
outcomes to the SRP.

Public health relevance
PROJECT NARRATIVE The focus of University of Kentucky Superfund Research Center (UK-SRC) is committed to developing an in- depth understanding of environmental health associated with exposure to organic pollutants as well as the development of protective technologies to aid in reduction of such exposure incidents. The proposed interdisiplinary training activites of the UK-SRC will be led and coordinated by the Research Experience and Training Coordination Core to successfully train skilled individuals who will positively impact our environmental health and the overall health of our nation.